Core A: Administrative Core

The objective of Core A is to supervise and facilitate overall progress of the scientific work of the
Program. Specifically, scientific management is combined in this Core with administrative support,
collection and molecular characterization of patient samples and biostatistics support. The
administrative component of the Core will provide strong scientific leadership to foster the overall
progress of research, scientific focus, integrity and ethical conduct and support to the Projects
and Core B. It will also be responsible for scheduling progress report meetings, integrating
research seminars with the Columbia Herbert Irving Comprehensive Cancer Center. The Edward
P.Evans Center for MDS and the Columbia Stem Cell Initiative seminar series and organizing
annual meeting with the external and internal advisory boards. Core will be responsible for
implementing integration of information from multiple sources, to facilitate the collection,
management and analysis of data and biospecimens. Core staff will arrange travel for the
members of the Program Project and the external visitors. The Clinical Translation component of
Core A will provide fundamental services and capabilities related to AML patient samples and
samples from healthy aging individuals. This component of the Core will expand, maintain, and
characterize the myeloid neoplasm tissue banks and clinical samples, and obtain, molecularly
characterize the AML patient samples maintain and characterize normal bone marrow tissue
samples. It will also provide experimental support for the creation of in vivo bone organoid
xenografts in mice. astly, the third component of this Core will provide comprehensive
biostatistical support to guide design of experiments, to optimize quantitative data analysis, and
to maintain statistical justification and interpretation of results.

Public health relevance
Narrative The objective of the Administrative Core is 3-fold: 1) to foster and facilitate overall progress of the scientific work of the Program foster, scientific focus, integrity and ethical conduct and support to the Projects and Core B; 2) to provide fundamental services and capabilities related to AML patient samples and samples from healthy aging individuals and support for xenograft organoid models; and 3) to provide biostatistical support.